Hemolysis and Platelet Activation during Continuous Flow Mechanical Circulatory Support

Project Summary / Abstract:
Heart failure (HF) has reached epidemic proportions effecting over 5.4 million people worldwide and its burden
is expected to grow exponentially in the next decade. Mechanical circulatory support (MCS) with continuous
flow (CF) pumps for patients with end stage heart failure or acute cardiogenic shock has led to drastic
improvements in survival. However, device operation remains fraught with serious adverse events (SAEs)
leading to excessive morbidity. CF pump thrombosis and stroke are occurring at high rates, thereby prompting
a need to uncover their hematologic mechanisms and therapeutic targets. In the chronic CF pump field, the
newly designed Heart Mate (HM) 3 device, with features of greater hemocompatability such as wider blood
flow passages, did show a reduction of in-situ pump thrombosis; however, the presence of disabling ischemic
stroke remained elevated. Such persistence of severe thrombotic events, despite alterations in device design,
makes it critically important to fully elucidate mechanisms underlying thrombus formation.
The association of hemolysis with device thrombosis and ischemic stroke has recently been recognized and is
consistent with a hemolysis induced pro-thrombotic state. Since overt clinical hemolysis may be a downstream
effect of thrombus already formed in the device and given that in-situ thrombosis may no longer occur in newer
generation of durable devices, we instead focus on assessing the in-vivo impact of sub clinical low level
hemolysis (LLH) on platelet activation and aggregation (PA/A). In hemolytic disorders such as sickle cell
anemia, extracellular hemoglobin may induce PA/A by scavenging nitric oxide (NO) and binding to pro-
thrombotic ultra large (UL) multimers of von Willebrand factor (vWF) to prevent their proteolysis by the
metalloproteinase (ADAMTS 13).
Our preliminary findings indicate that during both chronic and acute CF MCS, LLH was associated with a 7 to
15 fold increased risk of subsequent thrombotic events, including ischemic stroke. Moreover, we noted that
mean platelet volume (MPV), a surrogate marker of PA/A, and pro-thrombotic vWF levels were higher in
patients with LLH in comparison to those with no LLH. Our findings also indicate a substantial reduction in
thrombotic events and MPV with ongoing LLH during durable CF pump support in patients receiving a platelet
NO signaling potentiation agent, sildenafil.
This proposal will evaluate the hypotheses that LLH during CF pump support is associated with an increase in
PA/A and sildenafil can lower PA/A during LLH. In Aim 1, we will recruit patients on chronic (HM 2 and HM 3)
and acute (VA ECMO and Impella) CF MCS, to assess PA/A between those with and without LLH. In
secondary analyses, we will also examine whether this association may be related to changes in platelet
cGMP, vWF activity, vWF UL/HMW multimers and ADAMTS13 activity. In Aim 2, outpatients on durable CF
pump support with ongoing LLH will be randomized (1:1) to receive sildenafil or placebo in a double-blinded
manner for a 15 day period and changes in PA/A markers will be measured after assigned drug administration
and compared to baseline.

Public health relevance
The advent of continuous flow mechanical circulatory support (CF MCS) devices for patients with severe heart failure has led to marked improvements in survival; however, pump operation remains fraught with adverse thrombotic events such as stroke. Despite alterations in device design, the rate of disabling stroke remains elevated and the hematologic mechanisms behind these devastating adverse events remain unknown. This proposal will investigate if during CF MCS hemolysis creates a pro-thrombotic state through increasing platelet activation and if pharmacologic potentiation of nitric oxide signaling by an oral phosphodiesterase-5 inhibitor sildenafil lowers platelet activity. Elucidating mechanisms of hemolysis induced thrombosis may inform targeted anti-thrombotic strategies for prevention of end organ damage.